Investigating the role of apoptosis regulation in cancer therapy-induced vascular toxicities

PROJECT SUMMARY
Cancer treatments have evolved extensively over the past few decades, leading to vast improvements in
overall survival and cure rates. However, the collateral damage inflicted upon healthy tissues by both targeted
and cytotoxic agents frequently causes life-threatening irreversible toxicities. Some of the most common
toxicities include therapy-induced vascular impairments such as atherosclerosis, heart failure, ischemia, acute
thrombosis, and venous thromboembolism. Despite their widespread use, it is poorly understood how
chemotherapies and ionizing radiation cause vascular toxicities. Most cancer therapies typically induce
apoptosis (programmed cell death) by damaging common cellular components such as DNA or by blocking
critical signaling pathways. Since vascular cells are also exposed to these agents at high concentrations, they
could be vulnerable to therapy-induced apoptosis. However, the vasculature is comprised of several cell types
including vascular endothelial and smooth muscle cells; it is unknown which cells are sensitive to anti-cancer
agents and how they may contribute to long-term vascular dysfunction in patients. Using human induced
pluripotent stem cells (hiPSCs) for in vitro disease modeling, we will investigate vascular toxicities in hiPSC-
derived vascular endothelial cells and vascular smooth muscle cells. Utilizing robust differentiation protocols
already established in our laboratory, we will rigorously test how the survival and function of these cells are
affected by cancer treatments. We will also characterize the regulation of apoptosis in both vascular cell types
by measuring apoptotic priming and expression of BCL-2 family proteins. Additionally, we will look at the
functional and morphological changes that these cells undergo in response to cancer treatments that may
contribute to vascular toxicities. We hypothesize that each vascular cell type possesses differential levels of
apoptotic priming, and unique vulnerabilities to our panel of FDA-approved cancer therapies that drive therapy-
induced vascular toxicities. Our studies will elucidate potential mechanisms and determine contributions of
each cell type to vascular toxicities observed in cancer patients. Further, since aging is known to play a role in
both vascular toxicity and regulation of apoptosis, we will investigate how age affects apoptotic priming and
therapy sensitivity of vascular cells. We will replicate key experiments in mice at various life stages (neonate,
juvenile, adult and advanced age) to validate our in vitro findings and elucidate how age affects the
development of vascular toxicities. We will also utilize endothelial cell-specific BAX/BAK double knockout mice
to determine the extent to which apoptosis blockade can ameliorate vascular toxicity induced by cancer
treatment. Altogether, our work will test how apoptosis regulation affects the sensitivity of vascular cells to
chemotherapy and radiation and how this is altered by aging. These results will lay the groundwork for
improved therapy regimens in the clinic that may decrease long-term vascular toxicities in cancer patients.

Public health relevance
PROJECT NARRATIVE Life-threatening vascular toxicities reduce long-term quality of life in cancer patients after treatment and although this phenomenon has long been observed in the clinic, the mechanisms that cause this to occur remain unclear. We propose to investigate the mechanisms behind vascular toxicities by modulating the apoptotic machinery in cells within the vasculature and identify the contributions of each vascular cell type in response to various chemotherapies and radiation therapy. Our studies will ultimately lead to improved therapeutic strategies that will reduce vascular toxicity and improve health outcomes in cancer patients.